Enhancing research training for Maine Track / Tufts medical students

Over the past two decades, Maine Medical Center Research Institute, a component of MaineHealth, has built a
highly competitive research program encompassing basic, translational, clinical, and health services research
to support and enhance the healthcare needs of the state of Maine. Our focus on developing basic biomedical
research to support translational programs has been supported by the formation of Centers of Biomedical
Research Excellence (2000-present), and in 2017, a multi-institute Northern New England Clinical and
Translational Research Network to establish infrastructure required for extending clinical research efforts. We
have maintained a focus on medical training programs, with prominent academic affiliations with Tufts
University School of Medicine, with 40 of their medical students in a Maine Track program and 20 ongoing
residency and fellowship programs. Of note, recent expansions in graduate medical education include the
addition of a Rural Track in our Internal Medicine residency, and an enhanced focus on research as part of
residency and fellowships. These efforts have been bolstered by institutional investments to support medical
students and physicians in expanded options for research, and the alignment of research mentors with these
commitments. Research and clinical strengths at Maine Medical Center include topics of high relevance to the
mission of the NHLBI, including vessel wall biology, vascular development, myocardial injury, heart failure,
vascular progenitor cells, vascular inflammation, adipose/vascular interactions, endothelial dysfunction and
cardiovascular disease; and clinical research addressing cardiac arrest, cystic fibrosis, hemorrhagic shock,
vascular complications of trauma, and genetics/epidemiology of disease. This proposal requests the needed
support to fulfill the objective of the NHLBI to develop the biomedical research workforce focusing on a unique
population of medical students in Maine. This proposal requests funds to focus on providing rigorous, full-time
summer research training experiences for Maine Track medical students. While some of those students may
already have an interest in research, this new program will broaden our educational scope to include
translational biomedical research. Currently, all Maine Track students are required to complete a scholarly
project as part of their medical training, and we have an established infrastructure to support research
experiences in the summer after the first year of study. Our vision is to enhance this pipeline to increase our
community of rigorously trained physicians who are comfortable working across the basic-translational-clinical
research spectrum to promote public health. While this is a long-term and ambitious goal, it is even more
pressing in an environment such as the rural state of Maine, which does not have a portfolio of large academic
medical centers that attract a high number of medical students, residents or fellows interested in translational
research. This proposal requests funding for ten short-term summer experiences for medical students in the
Tufts Maine Track with experienced mentors committed to promotion of mentorship and training.

Public health relevance
This program will leverage the healthcare, research, and educational strengths of MaineHealth to provide training to medical students who have an interest in a professional career in Maine. Our vision is to increase the number of research-trained physicians, who will then be enabled to improve healthcare innovation across our rural state.